Penn Center for AIDS Research

Overall
ABSTRACT
The Penn CFAR provides dynamic scientific leadership, organizational structure, resources, & infrastructure to
advance AIDS research across the integrated campus of the University of Pennsylvania, Children’s Hospital of
Philadelphia (CHOP) & the Wistar Institute. The CFAR catalyzes cutting-edge science & adds value to the
Penn/CHOP/Wistar research enterprise through activities that could not be achieved by individual investigators
or projects. The Center is comprised of >150 members from our 3 institutions, including 9 of the 12 Penn schools
& 21 of 29 departments within the School of Medicine. CFAR success in the last 5 years is reflected in $217M
in NIH AIDS funding over that time, key discoveries in AIDS priority areas including HIV reservoirs/cure,
vaccine, immune function, prevention, health equity, implementation, comorbidities & other areas. The
CFAR’s proactive outreach & engagement has drawn new investigators from disparate fields across campus to
HIV/AIDS research; attracted 38 AIDS investigators newly appointed to faculty; established a vibrant
partnership with the Philadelphia Department of Public Health; advanced research & capacity-building with
the University of Botswana; & accelerated the pace of inclusion & diversity within the trainee, faculty & research
leadership communities & a new initiative with regional HBCU Lincoln University.
A comprehensive strategic planning process over the past year has led us to refine CFAR priorities, Cores,
SWGs & leadership to address emerging themes, leverage new expertise, cultivate new research leaders, &
maintain a cutting-edge focus. We are transitioning our highly successful Implementation Science SWG to a new
IS Core, establishing an innovative SWG focused on “HIV Communication & Policy Research”, & refining the
focus of our reservoirs SWG to “Single Cell Reservoirs & Immunology”. Looking ahead, the CFAR will support a
Developmental Core & 7 refined & revised Shared Resource Cores (Clinical, Virus & Reservoirs Technology,
Molecular & Translational Immunotechnology, Community Research & Engagement, Biostatistics & Data
Science, Implementation Science, & International) providing essential support for its research mission.
To address the opportunities & challenges of the next 5 years, the CFAR has 4 highly inter-linked Specific Aims:
(1) Provide scientific & administrative leadership & pilot funding to catalyze innovative, interdisciplinary research
that will lead to new knowledge & solutions for the AIDS crisis; (2) Attract, train, mentor & support the next
generation of AIDS researchers to ensure scientific progress, draw non-AIDS investigators into the field with
cross-cutting expertise, launch next generation research leaders, & exp& diversity in AIDS research &
leadership; (3) Support, monitor & continually evolve a set of efficient, dynamic & innovative Cores that both
support AIDS investigators & lead the research agenda through development & dissemination of innovative
technology that transforms scientific capacity, &; (4) Advance science & synergy through intra-campus, local,
national & international partnerships, community engagement, & capacity building.

Public health relevance
Overall PROJECT NARRATIVE The CFAR’s mission is to advance cutting-edge HIV/AIDS research on the Penn/CHOP/Wistar campus that will contribute innovative solutions to the AIDS crisis. The CFAR achieves this mission by providing scientific and administrative leadership to generate new research directions and collaborations; providing shared resource cores that support research through critical enabling technologies; leveraging institutional resources; training and mentoring the next generation of researchers and leaders and attracting scientists from other fields; and establishing partnerships and generating synergy with other groups on campus, in Philadelphia, nationally and internationally.